Tissue Procurement and Processing Core

TISSUE PROCUREMENT AND PROCESSING CORE
PROJECT SUMMARY/ABSTRACT
The overall mission of the Tissue Procurement and Processing (TPP) Core is to facilitate access and usage of
tissues and services to meet the specialized needs of the diabetes research community to expedite and catalyze
innovative diabetes research at UC AMC. This core will establish and expand resources to assist DRC
investigators with the acquisition and processing of rodent and human tissue, and specialized cell lines that are
broadly required for diabetes research. For the past 20 years, the services provided by the BDC-based facility
has provided high quality tissues to BDC investigators. DRC funding would allow us to expand access to all DRC
investigators studying the pathogenesis of Type1 (T1D) and Type 2 (T2D) diabetes. In addition, there is
increased need for primary human tissue. We have established a centralized facility to facilitate access to human
tissues from external sources (University of Alberta, Edmonton; see letter of support), and internally through the
UC-AMC Pathology Biorepository/Tissue Distribution Facility (see letter of support). Furthermore, administrative
support for the preparation of IRB approval, human exempt protocols and material transfer agreements for these
tissues will be available upon request by DRC members. The core will also provide diabetes-related
histopathology services, training in basic and specialized sample preparation and processing procedures, and
will offer DRC members access to resources such as validated commonly used reagents and equipment. Finally,
the TPP Core will provide a cell banking service to distribute validated diabetes-related cell lines to DRC
investigators. These services will facilitate individual studies, in addition to promoting collaborations between
investigators. Major services to be provided by the TPP core include 1) tissue preparation, including rodent and
human islet isolation and processing; 2) procurement of primary human tissues from local, national and
international sources; 3) sample processing for histological analysis; 4) validated and optimized reagents, such
as antibodies and probes; and 5) validated cell line distribution. These services have been selected based on a
campus-wide survey that solicited information from UC AMC diabetes investigators about their research needs.
These services have been selected based on a campus-wide survey that solicited information from UC AMC
diabetes investigators about their research needs. More than 65% of our DRC membership, which represents
>95% of our non-clinical research base indicated their need for tissue procurement and/or processing assistance.